Non-invasive Neuromodulation Unit (NNU)

Work was conducted under clinical protocols NCT03065335 and NCT03289923. Major accomplishments for the NNU were the recruitment of additional staff, acquiring research data from our first subjects in our collaboration with the Experimental Therapeutics and Pathophysiology Branch (ETPB), launching our initial multimodal protocol in combined TMS and talk therapy, installation and testing of neuromodulation equipment, expanding our training of staff to include additional labs at NIH as a core function, writing of software to implement experiments and collect and process data, protocol development and launch of the Multimodal Brain Stimulation speaker series. We now have a fully functional noninvasive neuromodulation laboratory operating for use with human subjects installed in the inpatient unit in the Clinical Center. Training in the safe and effective delivery of neuromodulation is one of our major functions as a Service within the Center for Multimodal Neuroimaging . To date, 67 individuals have received in-service training on TMS safety, 46 hands-on training sessions have been provided, 26 distinct individuals have received intensive hands-on training sessions (6 from NINDS, 3 from NIDA, 3 from NCCIH, and 14 from NIMH) including physicians, neuroscientists, advanced practice nurses, and students. Hands-on training sessions have covered the following procedures: Motor threshold determination, electromyography (EMG), Paired pulse TMS measures of cortical excitability, simultaneous TMS/EEG to measure TMS-evoked potentials, Somatosensory evoked potentials, Paired Associative Stimulation (a paradigm which induces neural plasticity), TMS-Safety procedures, and the role of Nursing in TMS and patient management. Our planned projects fall into 3 themes: 1) measuring neuroplasticity, 2) modulating neuroplasticity, 3) modeling the effects of neuromodulation and mining multi-modal datasets to discover biomarkers of rapid antidepressant response. Our projects include: Theme I: Measuring Neuroplasticity Mechanisms of Rapid Antidepressant Action collaboration with Drs. Zarate and Park o This project develops biomarkers of rapid antidepressant response through the addition of TMS-EMG, TMS-EEG and TMS-fMRI neuroplasticity measures to the existing intramural research program on ketamine, and adding a seizure therapy comparison arm. Concurrent fMRI-guided rTMS and cognitive therapy for the treatment of major depressive episodes o This project (which also incorporates Theme II, below) uses MEG (in collaboration with Allison Nugent (ETPB)), fMRI, and TMS/EEG to measure brain network engagement and neuroplastic changes due to multimodal TMS/CBT in depressed subjects. Theme II: Modulating Neuroplasticity We are taking complementary approaches to modulating neuroplasticity: 1) seizure-induced neuroplasticity, 2) paired associative stimulation (PAS) and 3) novel tool development to extend the spatial and temporal specificity of noninvasive neuromodulation. Next generation seizure therapy collaboration with Drs. Zarate, Park, Bikson, Datta o Therapeutically induced seizures exert rapid antidepressant action and are robust inducers of neurotrophic factors and neurogenesis. New technologies for focal seizure induction may improve the risk/benefit ratio by lowering cognitive side effects, and also provide the valuable scientific opportunity to examine common mechanisms across rapidly acting interventions such as ketamine. o This project involves optimization of seizure therapy dosing, through the study of individualized low amplitude seizure therapy (iLAST), comprised of focal seizure induction with minimal current exposure to improve tolerability of seizure therapy for depression. Cognitive Paired Associative Stimulation (C-PAS) o PAS has been shown to strengthen synaptic efficacy within a circuit through repeated co-activation and coincident firing. We extend that approach to activate a targeted neural circuit through cognitive task performance, and couple that with simultaneous focal neuromodulation to enhance plasticity, as a means of enhancing circuit function and improving the functional-specificity of neuromodulation action. One of our projects employs fMRI-guided TMS paired with a specific form of cognitive behavioral therapy for the treatment of depression (in collaboration with Dr. Strauman). Another of our projects, being conducted in the form of a cooperative agreement (5U01AG050618) uses fMRI-guided TMS with simultaneous working memory training to enhance executive function in older adults (in collaboration with Drs. Appelbaum, Peterchev, and Cabeza). Noninvasive focal deep brain stimulation (nfDBS) o Noninvasive brain stimulation is either focal and superficial, or deep and broad. Its utility as a clinical and research tool hinges on the ability to improve the spatial and temporal aspects of targeting. These projects address innovative approaches to improve the spatial resolution of TMS at depth, to precisely target deep brain structures and distributed networks of interest. Transcranial direction current stimulation to reduce effects of nicotine withdrawal syndrome NIDA Protocol 12-DA-N474 (PI: E.A.Stein, collaborators: Betty Jo Salmeron, Sarah Aronson) Symptoms of nicotine withdrawal remain a major impediment for smokers trying to quit, with most quit attempts failing within the first week of abstinence when withdrawal symptoms are at their height. Transcranial Direct Current Stimulation (tDCS) has the potential to modify neuronal circuits by application of a subthreshold conductive current through the scalp. The goal is to investigate the effects of tDCS on modulating large-scale brain networks dysregulated in nicotine addiction and withdrawal. Neural mechanisms underlying noninvasive brain stimulation assisted motor skill learning in older adults (Grant submitted to the Australian Research Council DP180101997) We combine animal and human models to examine the mechanisms underlying tDCS modulated motor skill learning in older adults and brain connectivity with a multimodal approach. Collaborators: PI: Hak Fujiyama, PhD, Murdoch University, Australia; Jeff Summers (UTAS); Stephan Swinnen (KU Leuven); Jennifer Rodger (UWA) Theme III: Modeling Neuroplasticity / Mining Multi-Modal Datasets Our team comprises engineering expertise to perform in silico modeling of the spatial and temporal effects of neuromodulation on neuronal function, and to apply machine learning and graph theoretical approaches to data-mining and hypothesis generation to support the discovery of common mechanisms across rapidly acting antidepressant interventions.